Reconstruction of a human blood-retina barrier and perfused vascular system to investigate the role of APOE variants in age-related macular degeneration

Project Summary/Abstract
Age-related macular degeneration (AMD) is a leading cause of vision loss after 50 years of age.
While genetic studies have identified various polymorphisms associated with AMD, there still is
no clear picture of the mechanisms leading to disease initiation and progression. The main
pathological hallmark of AMD is the accumulation of lipid-rich deposits, namely drusen,
between the retinal pigmented epithelium (RPE) and the choroid, leading to retina degeneration.
Several risk variants for AMD occur in lipid-related genes, including the apolipoprotein E
(APOE) gene, but their role in AMD is unknown. We hypothesize that differences in lipid
transport between APOE variants contribute to or inhibit AMD phenotypes. Unfortunately, there
are currently no model systems for a rigorous assessment of the interplay between genetic factors
and AMD pathology. Using induced pluripotent stem cell technology we developed an in vitro
human outer blood-retina barrier (oBRB) that includes RPE and a choriocapillaris-like
compartment and spontaneously forms sub-RPE deposits. Here, we propose to leverage these
technologies and generate genetically modifiable retina tissue to investigate interactions between
AMD phenotypes, lipid metabolism and APOE variants. In Aim 1, we will optimize the oBRB to
study AMD phenotypes in a robust system that can also be assembled from cryopreserved cells.
We will manipulate intrinsic and extrinsic factors to induce drusen in this system and correlate
with human postmortem eyes. Next, we will generate isogenic oBRBs with different APOE
variants to determine the mechanisms by which the APOE genotype influences AMD pathology
by comparing their transcriptomic, lipidomic and functional profiles. Since the contribution of
choriocapillaris hypoperfusion and function to the initiation of AMD is not well understood, in
Aim 2, we will integrate microvascular perfusion into our system to investigate how genetically
driven abnormalities affect AMD phenotypes. We will optimize a microfluidic approach with
microvascular perfusion, generating a perfused oBRB (poBRB). Next, we will use a panel of live
assays to investigate the contribution of APOE variants to poBRB vascular phenotypes and
correlate that with the spatial distribution of drusen-like deposits. Collectively, we will unravel
how APOE variants contribute to drusen formation, RPE and microvascular dysfunctional
phenotypes and pinpoint cellular subtypes responsible for APOE effect. We will also determine
the contribution of specific types of lipids to drusen formation. This work will establish a
multimodal retina modeling approach to study AMD phenotypes. We anticipate that our work
will reveal AMD therapeutic targets associated to lipid metabolism.

Public health relevance
Project Narrative Age-related macular degeneration (AMD) is a leading cause of vision loss after 50 years of age, with an estimated global prevalence of 288 million by 2040. We engineered an in vitro human outer blood-retina barrier tissue (oBRB) that replicates drusen-like deposits and is suitable to modelling genetic susceptibility in AMD. Here, we will further optimize and validate the oBRB and incorporate microvascular perfusion to investigate how genetic risk variants associated with lipid biology interact with multicellular and functional AMD phenotypes.